Adminstration

Core A (Administration) will be responsible for (1) fiscal management of the Udall Center for Excellence in Parkinson Disease Research, (2) insuring responsible conduct of research, and (3) promoting interactions between the Mayo Clinic and other Udall Centers. Moreover, it will provide scientific direction and accountability with the assistance of an External Advisory Committee, and it will be responsible for reporting to the NINDS.

Public health relevance
Core A provides essential services and oversight for the Udall Center, assuring compliance with federal regulations, as well as fiscal accountability and regular reporting of progress on research aims to the NINDS. Core A also fosters collaborations between Mayo Clinic and other Udall Centers and other NINDS initiatives, such as the Biorepository at Coriell and the Parkinson Disease Database at PD-DOC.